INSULIN AS REGULATOR OF SKELETAL MUSCLE BLOOD FLOW

Recent evidence suggests that insulin increases muscle glucose utilization by increasing blood flow through recruitment of new blood vessels. We hypothesize that insulin's action as a vasodilator in this fashion is blunted in the obese patient or the patient with Type 2 DM. We will examine total forearm blood flow using plethysmography and Doppler ultrasound and flow distribution using microbubble contrast ultrasound in 8 lean, 8 obese, and 8 Type 2 DM subjects before and after local insulin infusion.